Multi-Center Validation and Biologic Assessment of a Novel Pre-Transplant Biomarker Panel to Predict Liver Transplant Recipient Mortality

PROJECT SUMMARY
Due to organ shortage, livers are transplanted in order of recipient medical urgency; however, ethical principles
dictate avoidance of futile transplantation. The most common cause of death early after liver transplant (i.e.
futility) relates to consequences of an immune system which is frail or dysfunctional prior to transplant. We
have previously identified the Liver Immune Frailty Index (LIFI), a pre-transplant biomarker panel that
predicts risk of early post-transplant death. In our discovery cohort of 279 liver transplant recipients, pre-
transplant measurement of LIFI, based on HCV IgG, and plasma Fractalkine, and MMP3, can discriminate risk
of death within one-year following liver transplant with a c-statistic of 0.84 and a false-positive rate of 4%. LIFI-
low corresponds to 1.4% one-year mortality compared with 58.3% for LIFI-high. Multicenter validation is
necessary to advance the LIFI as an objective clinical index to predict the risk of liver transplant futility.
Mechanistically, our data suggest that immune frailty may relate to skewed intracellular energetics and immune
cell exhaustion. These alterations likely result from severe cirrhosis-associated immune dysfunction. In
preliminary studies, LIFI was determined at the time of transplant. Pre-transplant immune dysfunction is likely a
fluid process and may also be responsible for decompensation and death on the waitlist. Based on this, we
hypothesize that patients listed for LT exhibit both progressive pre-LT immune dysfunction (immune frailty) and
cirrhosis-related physical frailty, which predisposes patients to wait-list and early post-LT mortality. The
cumulative effect is detectable with serum biomarkers of immune dysfunction. To evaluate this, we have
established the Liver Immune Frailty Evaluation (LIFE) Consortium, comprised of six centers whose
volume encompasses almost 10% of annual US liver transplants. Plasma, PBMCs, radiographic, and clinical
data will be collected from waitlisted patients at LIFE centers. In Aim 1, we will perform multicenter validation
and refinement of the LIFI. In Aim 2, we will longitudinally assess biomarkers of immune dysfunction and AI-
driven body composition analysis (physical frailty) among waitlisted patients who either receive liver transplant
or who expire due to severe decompensation prior to or early post-liver transplant. We will also expand our
understanding of the development of immune frailty through targeted multiomic assessment. This study serves
as a direct extension and complement to our ongoing evaluation of severe pre-transplant immune dysfunction,
currently supported by a NIDDK K08 Award. Outcomes from this study will advance LIFI as a novel objective
index for pre-transplant patient assessment, and will expand understanding of immune frailty development.
IMPACT: LIFI is an innovative index that provides crucial insight into liver transplant candidate immune
function and risk of post-transplant mortality, and no alternative pre-transplant clinical indices provide this key
data. Validation and pre-transplant correlation of LIFI is critical to improve transplant timing, prevent wasting of
livers in high-risk patients, and identify therapeutic targets to reverse immune frailty and improve outcomes.

Public health relevance
PROJECT NARRATIVE Immune dysregulation appears central to liver transplant recipient immune dysfunction, frailty, and early death. We have identified the Liver Immune Frailty Index (LIFI), based on pre-transplant laboratory biomarkers of immune function, which accurately stratifies patients into low-, moderate-, and high-risk of early death post- transplant. This project aims to perform robust, multicenter validation of LIFI and longitudinal assessment of pre-transplant immune dysfunction to develop a more granular understanding of this process and to facilitate identification of targets for early intervention and improved transplant outcomes.